Research Program Core

Summary. Community health centers (CHCs) have unparalleled expertise in addressing health disparities in
marginalized U.S. communities, which have inequitably high vulnerabilities to the health impacts of climate
change. As the front line of primary care for these communities, CHCs are uniquely positioned to intervene to
prepare for and mitigate climate-induced health impacts in these populations. To do so effectively, CHCs must
be equipped with evidence regarding interventions that are successful in their patient populations. A crucial
first step is learning specifically how extreme climate events impact CHC patients’ health. The Research
Program Core of the Community Catalyst CCHRC will generate this critical knowledge by assessing
associations between climate-induced extreme heat events and wildfire-related poor air quality events and
health outcomes in CHC populations, with a focus on hypertension and asthma as prevalent diseases
managed in CHCs. The analyses will also consider the multi-level factors that may modify these associations.
These analyses will use 2013-2023 data from an EHR shared by a >1,700 CHC network spanning 36 states,
linked to granular climate event data. Working in bidirectional collaboration with the CHC community partners
in the CCHRC’s Community Engagement Core to ensure that analyses generate evidence that meets
community needs, we will test the hypotheses that: (1) Patients exposed to climate events will have an
increased incidence of elevated blood pressure, with an additive effect if exposed to both heat and poor air
quality, and a larger effect among patients with hypertension pre-event; there will also be increased incidence
of hypertension, kidney, and cardiovascular diseases among patients at risk for hypertension pre-event. (2)
Persons with asthma who are exposed to climate events will experience increased asthma exacerbation; there
will also be an increased incidence of asthma among exposed patients. Directed by our community partners,
we will build on these analyses’ results to (3) examine potential effect modifiers such as regional
characteristics and patient-level social risks and comorbidities, to enable identifying strategies that CHCs might
enact to prepare for and mitigate climate-induced health impacts, which will be assessed in future
effectiveness research. The analyses conducted here will provide the foundational evidence needed to develop
this community-prioritized research agenda.